Viral Load Trajectories and Dynamics among People Living with HIV in Rakai, Uganda: A Mixed-Methods Study

PROJECT SUMMARY
Background. To meet the UNAIDS 95-95-95 Fast Track targets for HIV epidemic control by 2030, strategies
that support people living with HIV (PLHIV) to achieve and maintain viral suppression must be prioritized. Rapid
scale-up of antiretroviral therapy (ART) through Universal Test and Treat policies has improved HIV treatment
outcomes at population level, but heterogeneities in the HIV epidemic and response have yielded disparities in
viral load outcomes. Examining longitudinal viral load outcomes, and the multilevel factors shaping them, is vital
for geographic prioritization and differentiation of HIV services to distinct groups of PLHIV.
Study Goal and Aims. The goal of this study is to assess patterns, predictors, and mechanisms underpinning
longitudinal viral load outcomes (or trajectories) among PLHIV in Rakai, Uganda. The specific aims of this study
are to: 1) Identify household and community-level predictors of virologic failure and durable viral suppression
among PLHIV at population level; 2) Examine health facility characteristics
associated with virologic failure
at
facility level; and 3) Explore the mechanisms through which social, contextual, and health systems factors
influence viral load outcomes. The proposed research aligns with NIMH Division of AIDS Research priorities to
advance design of interventions, delivered beyond the individual level, prolonging engagement in HIV care.
Approach. This explanatory, sequential mixed-methods study will leverage the data and infrastructure of the
Rakai Community Cohort Study (RCCS), an open, population-based cohort study of individuals aged 15-49 years
residing in 40 communities in Rakai, Uganda. Aim 1 is a secondary data analysis testing whether fishing
community residence, higher community-level migration, and lower household wealth are associated with
increased risk of virologic failure over five years of follow-up. Aim 2 will integrate RCCS data with programmatic
metadata from 161 health facilities to cross-sectionally identify compositional correlates of virologic failure in
each facility’s patient population. Building on findings from Aims 1-2, Aim 3 will involve primary qualitative data
collection through in-depth interviews with 20-24 PLHIV and 10-12 HIV clinicians. Interviews will explore
synergies in multilevel factors identified in Aims 1-2 and how they shape PLHIV’s viral load outcomes over time.
Findings from Aims 1-3 will be triangulated to enrich scientific inquiry into salient HIV treatment gaps.
Fellowship Information. The proposed research will serve as the doctoral dissertation of Mr. Joseph Rosen, a
PhD student at the Johns Hopkins Bloomberg School of Public Health. The training is guided by one Primary
Sponsor, three Co-Sponsors, and one Scientific Advisor with complementary methodological and topical
expertise, including care and treatment outcomes research with PLHIV in Rakai, Uganda. The training plan will
prepare Mr. Rosen to become a leading independent researcher in the social and behavioral sciences, focused
on interventions in sub-Saharan Africa supporting engagement and retention in HIV care.

Public health relevance
PROJECT NARRATIVE Expanded coverage of antiretroviral therapy (ART) through Universal Test and Treat strategies is credited for observable gains in population viral suppression across sub-Saharan Africa, but epidemiologic and policy heterogeneities have produced disparities in HIV treatment outcomes, including in Uganda, where fewer than 60% of people living with HIV (PLHIV) are virally suppressed. This mixed-methods study will investigate patterns and predictors of longitudinal viral load outcomes, specifically virologic failure and durable viral suppression , among PLHIV in Rakai, Uganda. Findings from this study—which innovatively integrates longitudinal population- based survey estimates and programmatic metadata from health facilities with primary qualitative data—will guide introduction and differentiation of HIV care and treatment interventions to PLHIV in order to accelerate progress towards the UNAIDS 95-95-95 Fast Track targets for HIV epidemic control by 2030.